Creating a niche for engineered live biotherapeutics

PROJECT SUMMARY
The long-term goal of this proposal is to improve outcomes of delivery of small molecules,
peptides, and proteins to the human gut by engineered live biotherapeutic bacteria. To
accomplish this, we will use two strategies to optimize biotherapeutic growth in the gut
environment. First, we will match prebiotic compounds (complex carbohydrates not digested by
the body) with heterologous expression of enzymes that allow cells to utilize these privileged
carbon sources. Second, we will create genome-scale libraries in our candidate biotherapeutics,
E. coli Nissle 1917 and Lactococcus lactis, to identify gene products that increase fitness in the
gut and gut-like environments. The methods will be tested in in vitro culture, small intestinal
organoid co-culture, and in vivo in the mouse gut to determine enrichment of the biotherapeutic
population, enhanced production of the therapeutic small molecule, peptide, or protein of
interest, and phenotypic outcome in systems of increasing verisimilitude to the human gut.

Public health relevance
PROJECT NARRATIVE This proposal seeks to enable the use of bacteria as live drug delivery vehicles by optimizing their growth and therapeutic production in the human gut. The public health relevance of this proposal is that successful implementation will allow for the treatment and diagnosis of disease by controlled delivery of sophisticated drugs without the need for injections.